RAISE-Botswana: Research on Aging, AD/ADRD, and Its Social Determinants in Botswana

PROJECT SUMMARY
The RAISE-Botswana project (Research on Aging, AD/ADRD, and Its Social Determinants in
Botswana) aims to develop infrastructure for aging and Alzheimer’s disease (AD) and Alzheimer’s disease-
related dementias (ADRD) research in Botswana, a country with an aging population and a high HIV burden.
RAISE-Botswana will support the career development of Dr. Lillian Okui, a research scientist and
epidemiologist at a Botswana research institution, through professional development activities and training
and mentorship from local, regional, and international experts in psychology, biostatistics, and epidemiology
of aging and the Harmonized Cognitive Assessment Protocol (HCAP) network in Kenya and South Africa.
The RAISE-Botswana professional development plan focuses on enhancing Dr. Okui’s skills in probability-
based sampling and epidemiological methods for AD/ADRD research, providing hands-on training in data
management, survey implementation, and tool adaptation. Additionally, it includes participation in webinars
and conferences to keep her informed on the latest advancements in aging and dementia research. RAISE-
Botswana will leverage the 2022 Botswana census datasets and the HCAP to gather baseline data on
the feasibility of population-based research for AD/ADRD in Botswana through three key aims: Aim 1:
Leverage the latest Census Dataset to develop a Sampling Frame and inform the study design for
Population-based Aging and AD/ADRD Research in Botswana. This sampling frame will enable accurate
and representative data collection, which is essential for estimating the prevalence and identifying risk factors
associated with AD/ADRD in Botswana. Aim 2: Adapt and translate the HCAP protocol, Respondent,
and Informant Interview Details for the Botswana context to ensure cultural relevance and linguistic
accuracy for use in Botswana. This will facilitate cross-national comparisons of cognitive health and dementia.
Aim 3: Assess the Acceptability and Feasibility of conducting population-based aging, AD/ADRD
surveys through a pilot study in Gaborone, Botswana, to provide critical baseline data for future
longitudinal studies. Implementing RAISE-Botswana will allow Dr. Okui to develop into a next-generation
researcher in aging and AD/ADRD. Expected outcomes include a sampling frame for AD/ADRD research,
adapted cognitive assessment tools, preliminary data for an R01 grant application, and enhanced capacity
for conducting probability-based sampling and survey analysis. This research will lay the groundwork for
future studies and inform public health strategies to address AD/ADRD in Botswana and other Sub-Saharan
African countries.

Public health relevance
PROJECT NARRATIVE The RAISE-Botswana project (Research on Aging, AD/ADRD, and Its Social Determinants in Botswana) will enable a Botswana-based research scientist and epidemiologist to transition into an independent aging and Alzheimer’s disease (AD) and related dementias (ADRD) researcher through training and mentorship from international, local, regional, and international experts in psychology, biostatistics and epidemiology of aging and the Harmonized Cognitive Assessment Protocol (HCAP) network in Kenya and South Africa. RAISE-Botswana will i) establish a population-based sampling frame for future aging and AD/ADRD research in Botswana by leveraging existing census data, and ii) adapt the HCAP to the Botswana context, enabling more accurate cognitive assessments and allowing for cross-national comparisons. Implementing a pilot household survey utilizing the adapted HCAP in one enumeration area of the Gaborone district of Botswana will provide information on the feasibility and acceptability of conducting population-based AD/ADRD research in Botswana and provide valuable preliminary data for future longitudinal studies.